CANCER CENTER SUPPORT (CORE) GRANT

Continued support is sought for a Specialized Cancer Center. The Center conducts basic cancer research in three inter-related program areas: (1) Gene Organization and Expression, (2) The Cytoskeleton, Cell Motility and Adhesion, and (3) The Genetics and Molecular Biology of Tumor Viruses. The Cancer Center faculty support their research through N.I.H. peer-reviewed individual grants. The present application seeks partial salary support for staff investigators, and funds for central services and common facilities.